Effects of particulate air pollution on HDL function and athersclerosis

The overall project aims to assess potential mechanisms on how exposure to air pollution leads to systemic effects consisting of increased lipid peroxidation, HDL dysfunction and enhanced atherosclerosis. Cumulative epidemiological and experimental data have shown that exposure to air pollutants leads to increased cardiovascular morbidity and mortality, especially of ischemic nature. We have found that exposures to diesel exhaust and ambient ultrafine particles (PM< 0.1 µm) lead to dysfunctional HDL characterized by reduced antioxidant and anti-inflammatory vascular protective properties. The development of dysfunctional HDL correlates with increased lipid peroxidation in systemic tissues and increased formation of atherosclerotic lesions. We have also observed that diesel exhaust leads to activation of the 5-lipoxygenase (5-LO) pathway in the liver. In the last few years, remarkable progress has been made in determining a plethora of systemic effects induced by air pollution. Many mechanistic details remain to be elucidated how air pollution leads to atherosclerosis. Our overarching hypothesis is that exposure to ambient PM results in lipid peroxidation, dysfunctional HDL and enhanced atherosclerosis via the induction of systemic prooxidant and proinflammatory effects that are mediated by the activation of macrophages and lipoxygenase pathways. We have proposed to test this hypothesis via three specific aims. During the bridging period funded by the R56 award, the effort will be focused on obtaining data to strengthen specific aims 1 and 2, as follows: 1) To evaluate whether activation of the 5-LO pathway mediates air pollution effects on lipid peroxidation, HDL dysfunction and atherosclerosis. We will explore the connections between 5-LO and Heme oxygenase-1 (HO-1) expression as well as the expression of other lipoxygenases in lungs, liver, aorta from ApoE null mice exposed to Diesel exhaust vs. filtered air. This will allow us to achieve a strong mechanistic framework between 5-LO and HO-1. 2) To assess the role of alveolar and systemic macrophages in the enhancement of lipid peroxidation, HDL dysfunction and atherosclerosis induced by air pollutants. We will expose macrophage-specific HO-1 KO mice in the ApoE null background and control littermates to diesel exhaust vs. filtered air to evaluate the impact of macrophage deletion of HO-1 on lipid peroxidation, HDL dysfunction and atherosclerotic lesions, and determine the connections between HO-1 and 5-LO. We will also develop mouse lung chimeras with ablated HO-1 and decreased antioxidant defense in their alveolar macrophages. These mice have a fluorescent reporter that will enable us to track HO-1 null alveolar macrophages and detect their migration from the lungs into systemic vessels, which will allow us to test the role of these cells in mediating systemic effects induced by diesel exhaust in future experiments.

Public health relevance
This project aims to understand the effects that exposure to air particulate matter produces on HDL function and atherosclerosis, an inflammatory process within the blood vessels that is initiated and propagated by the deposition of lipids and lipoproteins and that is the cause for cardiovascular ischemic diseases such as heart attacks and strokes, responsible for the largest number of deaths in the western world. DAVID GEFFEN SCHOOL OF MEDICINE AT UCLA Division of Cardiology Room BH-307 CHS 650 Charles E. Young Drive South Box 951679 Los Angeles, CA 90095-1679 Phone: (310) 825-3222 Fax: (310) 206-9133 Los Angeles, July 27th, 2014 Wanda Boggs Grants Management Specialist National Institute of Environmental Health Sciences Keystone Building, Room 3095 Research Triangle Park, NC 27709-2233 RE: R56 Award for application 2 R01 ES016959-06 (PI: Jesus Araujo). Dear Ms. Boggs and members of the Review Committee: It is my pleasure to submit the documents solicited for an R56 “bridge funding” award for application 2 R01 ES016959-06, “Effects of particulate air pollution on HDL function and athersclerosis”, by the National Institute of Environmental Health Sciences. Following documents are included: 1) Updated Other Support for the Senior Personnel of the R56 application. 2) Verification of IRB approval at UCLA for the proposed human subject project. 3) Verification that all individuals involved in the planning and conduct of human subjects research have completed the required training on the Protection of Human Subjects. This verification includes certificates for myself as well as Dr. Robert Brook and Robert Bard at the University of Michigan. 4) A narrative description of the proposed project reduced to 1-year. 5) Updated Specific Aims, Project Summary/Abstract, to reflect the reduction to a single year period. 6) Updated Planned Enrollment report, to reflect the reduced scope of work 7) Updated detailed budget and budget justification to reflect the reduced scope of work 8) Updated Human Subjects Section where the reviewers' critiques have been addressed. 2 9) Updated Animal section where the reviewers' critiques have been addressed. 10)A copy of the most recent signed F&A rate agreement Please do not hesitate to contact me for any additional information or documentation required, Respectfully yours, Jesus A. Araujo, MD, PhD. Associate Professor of Medicine E-mail: [email] Other Support Araujo, Jesus A. ACTIVE RO1 ES016959-01A1 (ONES Award, J. Araujo, PI) 07/01/09 – 06/30/15 2.4 calendar NIH/NIEHS $300,000 per year “Effects of particulate air pollution on HDL function and atherosclerosis The goal of this project is to assess the type of HDL alterations caused by exposure to air particulate matter. Role: PI Non-cost extension from 07/01/14 to 06/30/15. Renewal proposal submitted in November 2014. PO1 HL 30568, Project 1 (A. Fogelman, PO1 PI – 04/01/09 – 03/31/15 1.2 calendar J. Berliner & A. Lusis, Project PIs) $20,000 per year NIH/NHLBI “Regulation of Endothelial Cells by the Ox-PAPC Network” The goal of this project is to investigate molecular pathways regulated by Ox-PAPC in endothelial cells. Role: Co-investigator Non-cost extension from 04/01/14 to 03/31/15 Clean Air Research Center, Project 1 10/01/10 – 06/30/15 0.36 calendar (J. Harkema, PM Center PI, R. Brook, Project PI) $25,947 per year Environmental Protection Agency (EPA) “Cardiometabolic effects of exposure to differing mixtures and concentrations of PM2.5 in obese and lean adults” The goal of this project is to evaluate the cardiovascular effects of air pollutants < 2.5 µm in human subjects. Role: Co-investigator Pilot Project (J. Araujo, PI) 04/01/14 – 03/31/15 0.48 calendar Southern California Env Health Sciences Ctr (SCEHSC) $ 32,278 “Effects of Air Pollution on HDL Functionality” The goal of this project is to evaluate the cardiovascular effects of ambient air pollutants, rich in polycyclic aromatic hydrocarbons, on HDL function. PENDING R21 (J. Araujo, PI) 09/01/14-08/31/16 1.2 calendar National Institute of Environmental Health Sciences (NIEHS/NIIH) “Air Pollution, Fish Oil and HDL Function” The goal of this proposal is to evaluate the effects induced by air pollution and therapeutic role of fish oil PM- induced HDL dysfunction. Submitted in February 2014. Role: PI R21 (MPI - Y. Zhu, contact PI) 04/01/15-03/31/17 1.2 calendar National Institute of Environmental Health Sciences (NIEHS/NIIH) “Air Pollution and Cardiovascular Diseases: Identification of Novel Biomarkers” The goal of this proposal is to identify novel biomarkers of air pollution exposure in human subjects. A1 submission in July 2014. Role: PI OVERLAP None COLLABORATIVE INSTITUTIONAL TRAINING INITIATIVE (CITI) HUMAN RESEARCH CURRICULUM COMPLETION REPORT Printed on 07/27/2014 Jesus Araujo (ID: 1373188) 10833 Le Conte Avenue, CHS 43-264 LEARNER Los Angeles CA 90095 USA DEPARTMENT MEDICINE-CARDIOLOGY PHONE 310-825-3222 EMAIL [email] INSTITUTION University of California, Los Angeles (UCLA) EXPIRATION DATE 07/26/2017 HUMAN RESEARCH- BIOMEDICAL RESEARCHERS & STAFF COURSE/STAGE: Basic Course/1 PASSED ON: 07/27/2014 REFERENCE ID: 13450814 REQUIRED MODULES DATE COMPLETED History and Ethics of Human Subjects Research 07/27/14 Basic Institutional Review Board (IRB) Regulations and Review Process 07/27/14 Informed Consent 07/27/14 Records-Based Research 07/27/14 Research With Protected Populations - Vulnerable Subjects: An Overview 07/27/14 FDA-Regulated Research 07/27/14 University of California, Los Angeles (UCLA) 07/27/14 For this Completion Report to be valid, the learner listed above must be affiliated with a CITI Program participating institution or be a paid Independent Learner. Falsified information and unauthorized use of the CITI Program course site is unethical, and may be considered research misconduct by your institution. Paul Braunschweiger Ph.D. Professor, University of Miami Director Office of Research Education CITI Program Course Coordinator PEERRS Certification Record for Brook, Robert (robdbrok) Brook, Robert Uniqname or Friend Account: robdbrok UMID: 42831234 Date: Jul 25, 2014 The person named below has completed the indicated online modules in the University of Michigan's Responsible Conduct of Research training program, known as PEERRS (Program for Education and Evaluation in Responsible Research and Scholarship). PEERRS is a web-based foundational instruction and certification program for the members of the University of Michigan community engaged in or associated with research. Modules are offered on Foundations of Responsible Research Conduct; Research Administration; Conflict of Interest; Human Subjects Research; Animal Research; and Publications and Authorship. Each module consists of 20-30 web pages containing the core material, short case studies with questions, and pop-ups with additional information to provide greater depth and elaboration. Certifications are obtained by passing a test associated with each module. The certifications are valid through the dates shown. Active Certifications: Module Certified Through Conflict of Interest 11-09-2015 Foundations of Good Research Practices Module & Certification Test 11-09-2015 Human Subjects Biomedical & Health Sciences Module & Certification Test 11-09-2015 Research Administration Module & Certification Test 11-09-2015 Expired Certifications: Module Certified Through Conflict of Interest 12/04/2012 Foundations of Good Research Practice 12/04/2012 Human Subjects - Biomedical & Health Sciences 12/04/2012 Research Administration 12/04/2012 PEERRS Certification Record for Bard, Robert (bbard) Bard, Robert Uniqname or Friend Account: bbard UMID: 45097644 Date: Jul 25, 2014 The person named below has completed the indicated online modules in the University of Michigan's Responsible Conduct of Research training program, known as PEERRS (Program for Education and Evaluation in Responsible Research and Scholarship). PEERRS is a web-based foundational instruction and certification program for the members of the University of Michigan community engaged in or associated with research. Modules are offered on Foundations of Responsible Research Conduct; Research Administration; Conflict of Interest; Human Subjects Research; Animal Research; and Publications and Authorship. Each module consists of 20-30 web pages containing the core material, short case studies with questions, and pop-ups with additional information to provide greater depth and elaboration. Certifications are obtained by passing a test associated with each module. The certifications are valid through the dates shown. Active Certifications: Module Certified Through Human Subjects Biomedical & Health Sciences Module & Certification Test 12-19-2014 Expired Certifications: Module Certified Through Authorship, Publication and Peer Review 12/14/2008 Conflict of Interest 12/14/2008 Foundations of Good Research Practice 12/14/2008 Research Administration 12/14/2008 R56 Proposed Project A) Address of Critical Points from Summary Statement of 2RO1 ES016959-06 proposal. 1) Use of diesel exhaust particles for mouse studies while concentrated ambient particles are used in the human studies. This application aims to achieve a better mechanistic understanding of how the inhalation of air pollutants leads to systemic effects including increased lipid peroxidation, development of dysfunctional HDL and atherosclerotic lesions using diesel exhaust (DE) as a model pollutant, highly prevalent in urban settings. This choice is driven by the necessity of using a relatively stable reagent that can lead to similar magnitudes of effects from experiment to experiment in spite of the fact that ambient particulate and CAPs exposures offer a more “realistic” scenario, but characterized by a much larger variability which limits reproducibility and comparison among different experiments. Therefore, for the human translational studies in aim 3, since human subjects can not be experimentally exposed to diesel exhaust for several hours or days, we will study the effects of air pollutants on HDL using a time-series design where individuals will be exposed to “real life” levels of ambient PM, which will be highly relevant. However, for the mechanistic studies in mice, inhaled DE exposures will offer a more reproducible experimental system than the highly variable ambient PM or CAPs, as the composition of the “reagent” to study (PM) is more reproducible by controlling the type of fuel and variables involved in its combustion, better suited for the determination of toxicological variables such as dose and kinetics and the mechanistic investigation that will be conducted in aims 1 and 2. 2) The use of two different sampling sites (Michigan and Beijing) is a confounding factor due to the likelihood of different composition of these PM2.5. We will investigate the effects of varying levels of ambient PM on human HDL function in Ann Arbor, MI and Beijing, China where PM is at low and very high concentrations, respectively. The primary analyses will be focused on determining whether ambient PM alters HDL functionality in human subjects within each city, where the composition of the PM is the same. This will allow us to determine if a higher PM exposure correlates with a higher HOI in two different cities, with markedly different PM concentrations. In case we do not observe positive associations in subjects residing in Ann Arbor and/or Beijing, we will establish comparisons between those. In the latter analyses, several more variables will be statistically controlled to enable a meaningful comparison between both settings. While it is true that not only PM concentration but PM composition will be different, it would be highly significant to detect whether different PM concentrations/composition can induce significant effects on HDL function and this will support the design of future studies to address this. Importantly, on-going analyses of our studies using samples from the Cleanair Study, funded by the RO1's first period period, is now showing that only 2-hour exposures to CAPs PM2.5 led to an increase in HOI that was significantly different (p< 0.05) than the HOI exhibited by subjects exposed to Ozone. This markedly increases the probability that we will be able to detect significant variation in the HOI of subjects exposed to varying PM levels over several days and within each city, in Aim 3 of the proposal. B) Proposed Work for R56 Award Experimental work will be conducted within the next year to acquire data that allows addressing important points such as: a) lack of a strong mechanistic framework between 5-LO and HO-1 in Aim 1 and Aim 2, b) lack of preliminary data showing that exposure to DE leads to accelerated atherosclerosis, c) lack of entertaining the possible involvement of multiple lipoxygenases in air PM-mediated pro- atherogenic effects, which could pose difficulties to interpret results of 5-LO KO studies, d) lack of preliminary data showing the ability of alveolar macrophages to migrate in circulation. We plan to conduct studies where macrophage-HO-1-/-, ApoE-/- mice and HO-1+/+, ApoE-/- control mice will be exposed to DE vs. filtered air for 2 weeks. We will study: i) HDL antioxidant capacity, ii) Lung and systemic lipid peroxidation, iii) expression of 5-LO and other lipoxygenases in alveolar and peritoneal macrophages, lungs, liver, aorta and spleen, which will allow us to address points a, b and c. We would also like to conduct an experiment with the mouse lung chimeras proposed in aim 2, to determine whether resident macrophages in the lungs can migrate to systemic tissues. The presence of the red fluorescence reporter in the lung macrophage HO-1 KO chimeras will allow us to address point “d” by tracking their translocation into tissues such as lymph nodes, liver, heart and aorta. Modified Project Summary/Abstract Section The overall project aims to assess potential mechanisms on how exposure to air pollution leads to systemic effects consisting of increased lipid peroxidation, HDL dysfunction and enhanced atherosclerosis. We have found that exposures to diesel exhaust and ambient ultrafine particles (PM< 0.1 µm) lead to dysfunctional HDL prooxidant and proinflammatory HDL that correlated with increased lipid peroxidation in systemic tissues and increased formation of atherosclerotic lesions. We have also observed that diesel exhaust led to activation of the 5-lipoxygenase (5-LO) pathway in the liver. Many mechanistic details remain to be elucidated how air pollution leads to atherosclerosis. Our overarching hypothesis is that exposure to ambient PM results in lipid peroxidation, dysfunctional HDL and enhanced atherosclerosis via the induction of systemic prooxidant and proinflammatory effects that are mediated by the activation of macrophages and lipoxygenase pathways. In the year funded by the R56, we will acquire tools and preliminary data that will enable us to test this hypothesis in the future application via three specific aims: 1) To evaluate whether activation of the 5-LO pathway mediates air pollution effects on lipid peroxidation, HDL dysfunction and atherosclerosis. We will explore the connections between 5-LO and Heme oxygenase-1 (HO-1) expression as well as the expression of other lipoxygenases in lungs, liver, aorta from ApoE null mice exposed to Diesel exhaust vs. filtered air. This will allow us to achieve a strong mechanistic framework between 5-LO and HO-1. 2) To assess the role of alveolar and systemic macrophages in the enhancement of lipid peroxidation, HDL dysfunction and atherosclerosis induced by air pollutants. We will expose macrophage-specific HO-1 KO mice in the ApoE null background and control littermates to diesel exhaust vs. filtered air to evaluate the impact of macrophage deletion of HO-1 on lipid peroxidation, HDL dysfunction and atherosclerotic lesions, and determine the connections between HO-1 and 5-LO. We will also develop mouse lung chimeras with ablated HO-1 and decreased antioxidant defense in their alveolar macrophages. These mice have a fluorescent reporter that will enable us to track HO-1 null alveolar macrophages and detect their migration from the lungs into systemic vessels, which will allow us to test the role of these cells in mediating systemic effects induced by diesel exhaust in future experiments. 3) To provide important “real-world” corroboration of the relevance of the animal studies, we will evaluate the effects of subacute exposure to air particulate matter on HDL function in human subjects by determining if there are associations between the concentration levels of ambient PM and changes in HDL antioxidant function. During the R56-funded year, participating subjects will be recruited and the collection of blood samples started. Determining potential mechanisms and whether PM exposure induces effects on HDL functionality in humans would be of enormous importance as they may illuminate on the pathogenesis and could lead to identifying novel biomarkers of PM-mediated health effects. Modified Specific Aims Section Air pollution has been associated with significant adverse health effects leading to increased morbidity and mortality. Cumulative epidemiological and experimental data have shown that exposure to air pollutants leads to increased cardiovascular ischemic events and potentiated atherosclerotic development . These associations are much stronger with the air particulate matter (PM) than with the gaseous components, with smaller particles appearing to be the most pathogenic [1, 2]. We have shown that ambient ultrafine particles preferentially promote atherosclerosis, partly due to their high content in redox cycling chemicals and their ability to synergize with known proatherogenic mediators in promoting tissue oxidative stress and systemic proinflammatory effects [3]. In the current funding period, we have found that exposures to ambient ultrafine particles (PM<0.1 µm in aerodynamic diameter) and diesel exhaust (rich in ultrafine PM), lead to prooxidant effects in the lungs and in systemic tissues; these effects associate with the development of dysfunctional HDL in the plasma, characterized by reduced antioxidant and anti-inflammatory vascular protective properties [4, 5]. This prooxidative and proinflammatory dysfunctional HDL has been shown to be a predictor for cardiovascular diseases [6, 7]. In addition, we determined that HDL dysfunction was associated with enhanced plasma levels of HETEs and HODEs (oxidative products of arachidonic and linoleic acid, respectively), activation of the 5- lipoxygenase (5-LO) pathway in the liver, and the development of atherosclerosis [4, 5]. Oxidation of arachidonic acid by 5-LO leads to the generation of a family of leukotrienes with strong inflammatory effects in a variety of disorders. Thus, 5-LO has been shown to mediate inflammation in the liver [8], adipose tissue [9] and promote atherosclerosis [10, 11]. In the last few years, remarkable progress has been made in determining a plethora of systemic effects induced by air pollution. However, many mechanistic details regarding the pathways whereby PM inhalation instigates these detrimental systemic actions remain to be elucidated. The observations that particle uptake by alveolar macrophages significantly correlates with the development of atherosclerotic plaques [12, 13] strongly suggest that these cells are likely to be important mediators in translating effects from the lungs to the systemic tissues. Our overarching hypothesis (Figure 1) is that exposure to ambient PM results in lipid peroxidation, dysfunctional HDL and enhanced atherosclerosis via the induction of systemic prooxidant and proinflammatory effects which are mediated by the activation of macrophages and lipoxygenase pathways. We propose to test this hypothesis via three specific aims: Specific aim 1. To evaluate whether activation of the 5-lipoxygenase pathway mediates air pollution effects that promote lipid peroxidation, HDL dysfunction and atherosclerosis. In the initial period, we have found that 2-week exposure to diesel exhaust leads to activation of the 5-LO pathway in the liver [5]. In the year funded by the R56, we will explore the connections between 5-LO and Heme oxygenase-1 (HO-1) expression as well as the expression of other lipoxygenases in lungs, liver, aorta from ApoE null mice exposed to Diesel exhaust vs. Filtered air. This will allow us to achieve a stronger mechanistic framework between 5-LO and HO-1, requested by the reviewers of the proposal submitted for the RO1 renewal. Specific aim 2. To assess the role of alveolar and systemic macrophages in the enhancement of lipid peroxidation, HDL dysfunction and atherosclerosis induced by air pollutants. Heme oxygenase 1 (HO-1) is a critical enzyme in orchestrating the cellular antioxidant and anti-inflammatory defense [14]. Systemic HO-1 KO mice exhibit enhanced atherosclerosis [15] and dysfunctional HDL. We have developed macrophage-specific HO-1 KO mice in the ApoE null background during the current period. In the year funded by the R56, we will expose macrophage-specific HO-1 KO mice in the ApoE null background and control littermates to diesel exhaust vs. filtered air to evaluate the impact of macrophage deletion of HO-1 on lipid peroxidation, HDL dysfunction and atherosclerotic lesions, and determine the connections between HO-1 and 5-LO. We will also develop mouse lung chimeras with ablated HO-1 and decreased antioxidant defense in their alveolar macrophages. These mice have a fluorescent reporter that will enable us to track HO-1 null alveolar macrophages and detect their migration from the lungs into systemic vessels, which will allow us to test the role of these cells in mediating systemic effects induced by diesel exhaust in future experiments. Specific aim 3. To provide important “real-world” corroboration of the relevance of the animal studies by evaluating the effects of subacute exposure to air particulate matter on HDL function in human subjects. During the RO1 initial period, we developed a sensitive and reproducible assay to evaluate the HDL antioxidant capacity in humans [5, 16]. We will use this assay to determine whether subacute exposures to PM2.5 result in the development of dysfunctional HDL in human subjects residing in Michigan (low concentration of PM2.5) and subjects residing in Beijing (high concentration of PM2.5). We have obtained IRB approval at UCLA for the prospective collection of human samples, which will be performed by investigators in Michigan and Beijing, in the year funded by the R56, and subsequent evaluation of lipid peroxidation and HLD functional parameters at UCLA, in the years funded by the 2RO1 ES016959-06. Modified Public Health Relevance Section This project aims to understand the effects that exposure to air particulate matter produces on HDL function and atherosclerosis, an inflammatory process within the blood vessels that is initiated and propagated by the deposition of lipids and lipoproteins and that is the cause for cardiovascular ischemic diseases such as heart attacks and strokes, responsible for the largest number of deaths in the western world. Planned Enrollment Report This report format should NOT be used for collecting data from study participants. Study Title: Effects of sub-acture exposures to air particulate matter on HDL function in Michigan and Beijing. Domestic/Foreign: Domestic Comments: 50 subjects will be enrolled in Michigan, US and 50 subjects in Beijing, China. Ethnic Categories Not Hispanic or Latino Hispanic or Latino Total Female Male Female Male American Indian/ Alaska Native 0 0 0 0 0 Asian 27 27 54 Native Hawaiian or Other Pacific Islander 0 Black or African American 3 3 6 White 19 19 1 1 40 More Than One Race 0 Total 49 49 1 1 100 Racial Categories PHS 398 / PHS 2590 (Rev. 08/12 Approved Through 8/31/2015) OMB No. 0925-0001/0002 Page Planned Enrollment Report Principal Investigator/Program Director (Last, first, middle): Araujo, Jesus DETAILED BUDGET FOR INITIAL BUDGET PERIOD DIRECT COSTS ONLY FROM 07/01/14 THROUGH 06/30/15 PERSONNEL (Applicant organization only) NAME ROLE ON PROJECT TYPE APPT (months) % EFFORT ON PROJ INST BASE SALARY DOLLAR AMOUNT REQUESTED (omit cents) SALARY REQUESTED FRINGE BENEFITS TOTAL Benefit Rate: Araujo, Jesus Co-PI 12.0 20% 181,500 0 0 Yin, Fen SRA IV 12 40% 57,708 23,083 10,503 Gajalakshmi Ramanathan SRA I 12 65% 39,264 25,522 6,432 0 29% 33,586 45.5% 31,954 25.2% 0.00% SUBTOTALS 48,605 16,935 65,540 CONSULTANT COSTS 0 EQUIPMENT (Itemize) 0 SUPPLIES (Itemize by category) Regants for sample analysis and lab supplies 10,000 DLAM Per Diem 24,026 34,026 TRAVEL 0 PATIENT CARE COSTS INPATIENT 0 OUTPATIENT 0 ALTERATIONS AND RENOVATIONS (Itemize by category) 0. 0 OTHER EXPENSES (Itemize by category) TIF 434.00 434 SUBTOTAL DIRECT COSTS FOR INITIAL BUDGET PERIOD $ 100,000 UCLA DIRECT DIRECT COSTS FACILITIES AND ADMINISTRATION (F&A) COSTS 100,000 54,000 TOTAL BUDGET: DIRECT & INDIRECT/F&A COSTS FOR INITIAL BUDGET PERIOD $ 154,000 CONSORTIUM/CONTRACTUAL COSTS TOTAL DIRECT COSTS FOR INITIAL BUDGET PERIOD $ TOTAL INDIRECT/F&A COSTS FOR INITIAL BUDGET PERIO RATE: 54.00% $ UCLA INDIRECT BUDGET JUSTIFICATION Personnel All salary and fringe benefit calculations are based on current amounts of the University of California Office of the President. Dr. Jesus A. Araujo, MD, PhD. Principal Investigator (2.4 calendar months, no salary requested). Associate Professor of Medicine at UCLA School of Medicine, has extensive research training in cell and molecular biology, lipidology, immunology as well as clinical training in Internal Medicine, Cardiology and Echocardiography. Dr. Araujo has been a pioneer in the research field of Environmental Cardiology, with strong experience in the conduction of multidisciplinary teams and tasks. His laboratory was the first to demonstrate the proatherogenic effects of ambient ultrafine particles and provided the first evidence that these effects include the alteration of HDL function. He also has a strong record in the study of oxidative stress and inflammation in the vasculature as well as determining the role in atherosclerosis of anti-oxidant genes such as Heme oxygenase-1 and its transcription factor Nrf2. Dr. Araujo will be responsible for overseeing all the work proposed in this R56 Project Award. The PI will plan the experiments in consultation with Dr. Rosenfeld, collaborative investigator at the University of Washington. He will coordinate quality assurance and will act as liaison between his collaborators and members from his own laboratory. Dr. Araujo will conduct data interpretation, participate in the writing and oversee publication of manuscripts on this project. OTHER PERSONNEL Dr. Fen Yin, M.Sc., Ph.D., Staff Research Associate IV (4.8 calendar months), is an experienced biochemist and vascular biologist with broad experience in biochemical techniques, molecular biology, tissue culture and handling of mice. She is the first author of two recent studies where she developed a novel technique for the assessment of HDL antioxidant capacity and used it to demonstrate the effects induced by diesel exhaust emissions on the generation of dysfunctional prooxidant HDL. In addition, she determined that diesel exhaust led to activation of the 5-lipoxygenase (5-LO) pathway in the liver, accompanied by increased content of cholesterol and triglycerides. She will conduct the experiments aimed to evaluate the interaction between 5-LO and heme oxygenase 1 (HO-1) in this R56 award. She will assess expression of 5-LO and other lipoxygenases in alveolar and peritoneal macrophages, lungs, blood leukocytes, liver, aorta and spleen in the experiments contemplated in this R56 award. She will be working under the direct supervision of Dr. Araujo. Dr. Gajalakshmi Ramanajan, B.Sc., M.Sc., PhD. Postdoctoral Fellow (7.8 calendar months), recently obtained her Ph.D. degree in Laboratory Medicine at the Medical University of Vienna in Austria. She worked in our laboratory for 1 ½ years while completing her Ph.D. She has been outstanding in the assessment of plasma lipoproteins in human subjects including HDL antioxidant capacity and enzymatic assays such as paraoxonase. She co-authored two publications and is currently writing a first-author manuscript on the differential effects of 2-hour exposures to concentrated PM2.5 and ozone. She will assess HDL antioxidant capacity, paraoxonase activity, measures of lipid peroxidation and analyses of atherosclerotic lesions in experiments contemplated in this R56 award. She will also develop HO-1 knockout mouse lung chimeras, proposed to be used in second aim of the RO1 renewal proposal, and test whether resident macrophages in the lungs can migrate to systemic tissues, as inquired by the reviewers in the summary statement. She will perform data analyses and participate in the writing of manuscripts. She will be working under the direct supervision of Dr. Araujo. Direct Costs Animals ($24,026) include macrophage-specific HO-1-/- mice in the ApoE null background as well and HO-1+/+ mice in the ApoE null background will be used as controls. Colonies of macrophage-specific HO-1 KO and ApoE KO mice are already established and on-going in the UCLA vivaria. Mice will be fed a chow diet and subjected to diesel exhaust (DE) vs. filtered air for at least 2 weeks. Maintenance costs for mice are based on a per diem charges. Materials and Supplies ($10,000): Tissue culture plasticware ($1,000) includes disposable serological pipettes, Petri dishes, multi-well plates, filters for sterilizing media, sterile plastic tubes, freezing vials. Tissue culture ($1,000) reagents include culture media, fetal bovine serum, glutamanine, trypsin, matrix gel, antibiotics. Reagents for DCF-based cell free assays for assessment of HDL function ($1,000) include tissue culture plates, chambers, DCF, cholesterol reagent. Antibodies ($1,500) are required for Western blotting, immunohistochemistry and FACS analyses. Reagents for Molecular Biology ($3,000) include DNA polymerase, reverse transcriptase, restriction enzymes, siRNA, oligonucleotide primers, DNA purification columns, autoradiography film, polyacrylamide gels. Histology ($400) includes cost for fixation, histochemical stains, slides, cover slips, sample preparation General Laboratory Supplies ($2,100) includes supplies for gel electrophoresis, glass ware (bottles, beakers), pipettes, pipette tips, pipettors, disposable containers and cuvettes, gloves, bleach, towels, microfuge tubes, scintillation vials. Technology Infrastructure Fee ($434) Technology service fee charge for campus network, backbone, internet connection, hardware, wireless services, etc. This is based on a full-time employee (FTE) and is calculated at $34.46 per FTE per month. We anticipate this expense will costs will be as follows: E. HUMAN SUBJECTS RESEARCH 1. Human Subjects Involvement and Characteristics: A total of 300 blood samples collected from 100 individuals to be recruited as a part of the “Particulate Matter Air Pollution and High Density Lipoprotein Dysfunction” led by co-investigator Robert Brook. This is a panel study where participating individuals will be exposed to low and high ambient levels of air pollution in Michigan and Beijing respectively. 50 subjects will be recruited at the University of Michigan (UM) site and 50 subjects will be recruited at the Peking University (PKU) site. All subjects will have a thorough exposure characterization for 7 days prior to the collection of blood draws (2 samples per subject). They will also have a cardiovascular (CV) parameters evaluated that will include Brachial Blood Pressure (automated Omron device), aortic hemodynamics and compliance by pulse wave velocity (PWV), basal arterial tone will be evaluated ...